Disparities in early life educational environment and AD/ADRD: leveraging administrative linkages in a unique occupational cohort

Abstract
Racial disparities in Alzheimer’s disease and related dementias (ADRD) have been well documented. At the
same time, there is increasing scientific evidence that early life condition and particularly early-life education
are key modifiable risk factors for ADRD. However, there is a critical lack of data and knowledge about how
early-life education may protect against later-life ADRD risk separately for Black and white adults. To fill this
gap, we propose to leverage and expand an existing, well documented occupational cohort of autoworkers at
General Motors (GM) between 1938-1994. We will use historic census linkages to capture the cohort’s early
life educational environment and linkages with Centers for Medicare and Medicaid Services (CMS) data to
capture their chronic conditions and ADRD diagnoses. Importantly, this cohort includes a relatively large
number of Black workers, most of whom lived in various parts of the South as children but migrated north to
Michigan by midlife, and all worked at unionized auto plants with good medical benefits. Our central hypothesis
is that, despite having similar jobs and access to healthcare in midlife, access to quality education in early life
will be related to ADRD risk within racial categories, with a stronger relationship for Black autoworkers.
To examine the association between early life education and ADRD, we will first characterize the cohort’s
overall and ADRD disease profile by race by linking the autoworkers cohort with CMS chronic disease files. We
will then describe census-level household characteristics (parental education and parental occupation) and
childhood circumstances (racial segregation, child mortality, area wealth, education availability/quality) within
Black and white GM autoworkers by linking the UAW-GM cohort with historical census data. Finally, we
propose to estimate the association between availability and quality of educational opportunities in childhood
and later-life ADRD risk separately for Black and white UAW-GM workers born 1920-1940. By leveraging a
cohort of older adults defined by their similar mid-life work experiences, but with vastly different early life
educational opportunities, we can isolate those parts of the education-ADRD relationship that are not mediated
by employment quality or healthcare access in adulthood.
The research team includes epidemiologists, a health policy economist, and data analysts with extensive
experience working with this cohort, administrative data, and historical census linkage projects. The study team
has substantial statistical modeling experience but are relatively new to ADRD research and eager to collect
preliminary data to support future work in this substantive area.

Public health relevance
Narrative Racial disparities in Alzheimer’s disease and related dementias (ADRD) have been well documented and there is increasing scientific evidence that early-life education is a key modifiable risk factor for ADRD. We propose leveraging and expanding an existing cohort of autoworkers at General Motors (GM) to test the hypothesis that, despite having similar jobs and access to healthcare in midlife, access to quality education in early life will be related to ADRD risk, specifically among Black autoworkers. We will characterize the cohort’s ADRD profile by linking to Centers for Medicare and Medicaid Services data, describe early life characteristics by linking to historical census data, and model the association between early life education opportunity and ADRD risk separately among Black and White autoworkers.